Targeting Oncogenic PKA signaling mechanisms

ABSTRACT
Of the 6,500 known rare diseases, only about 5% have U.S. Food and Drug Administration-approved treatments.
In cancer, rare tumors account for approximately 20% of cancer incidence but often lack established therapeutic
regimens. Hence, gaining a molecular understanding of rare tumors is key for development of effective therapies.
This multi-investigator proposal investigates oncogenic mutations that activate protein kinase A (PKA) to promote
defective cell signaling in rare endocrine and hepatic tumors.
Targeted therapeutics have transformed care for patients with rare cancers by targeting oncogenic mutations in
protein kinases. PKAc-driven cancers are challenging to target in this way because this broad specificity kinase
controls myriad physiological processes. Consequently, selective PKAc inhibitors have been relegated to the
role of tool compounds rather than clinically viable drugs. Thus, alternative strategies must be developed to treat
PKAc-driven cancers. Our preliminary profiling of oncogenic PKAc mutants provide compelling evidence that
PKAc engages downstream protein kinase cascades that impact translation in adrenal and hepatic tumors. We
also observed increased mRNA translation as an emerging hallmark of these PKAc driven malignancies. These
findings have forged a working hypothesis that PKAc-driven cancers can be treated by targeting downstream
effectors such the RNA helicase eIF4A rather than globally blocking the catalytic activity of the kinase.
Three specific aims will test this transformative premise. 1) Proteomic and transcriptomic profiling of cells
expressing oncogenic PKAc variants that underlie Carney complex, Cushing’s adenoma and fibrolamellar
carcinoma will elucidate downstream signaling elements that impinge on mRNA translation. 2) Molecular
approaches will investigate new properties imparted by the DNAJ-PKAc-chimeric kinase in fibrolamellar
carcinoma that may confer resistance to chemically induced apoptosis. 3) Clinically relevant compounds and
novel bivalent inhibitors will dissect the mechanism of eIF4A dependence in PKAc-driven malignancies and
patient derived (PDX) models of fibrolamellar carcinoma. This proposal not only builds on a solid foundation of
PKAc research, but also affords an unparalleled opportunity to discover, develop and validate drug targets for a
group of patients in dire need.

Public health relevance
PROJECT NARRATIVE Aberrant Protein Kinase A (PKA) signaling drives the growth and progression of a subset of lung, ovarian, liver, adrenal and gastrointestinal tumors. Pharmacologically targeting these aggressive cancers is challenging as directly inhibiting PKA has dire consequences such as heart failure, kidney dysfunction and diabetes. This multi- investigator project tests if PKAc-driven cancers can be treated by targeting its downstream effects on mRNA translation by inhibiting the helicase eIF4A rather than globally blocking the activity of the kinase.